Sterile inflammation and pyroptotic cell death in liver fibrosis

The NLRP3 inflammasome is a multi-protein cytoplasmic complex functioning as a pattern
recognition receptor that has emerged as a key regulator of sterile inflammation and cell death.
NLRP3 activation leads to secretion of mature IL-1β and IL-18. Caspase 1 activation can also
initiate a distinct form of programmed cell death (pyroptosis) mediated via processing of
Gasdermin D and formation of discrete pores in the plasma membrane. Using single cell RNA
transcriptomics (scRNA-seq) we demonstrated that time-controlled, inducible global NLRP3
inflammasome activation results in 1) shifts in liver macrophages characterized by depletion of
KCs and infiltration of monocyte-derived macrophages (MdMs); 2) liver infiltration with
proinflammatory neutrophils; 3) increased activated myofibroblastic HSCs; 4) an enhanced role
for NLRP3 inflammasome driven by IL-18; 5) These changes are associated with chronic
inflammation, increased collagen deposition and development of liver fibrosis. Based on our
published and novel preliminary data we propose the CENTRAL HYPOTHESIS that NLRP3
inflammasome regulated changes in the innate immune cell niche in the liver is a central
mechanism that triggers myofibroblastic HSC activation, and liver fibrosis driven by IL-18. To
investigate this hypothesis our proposal has following SPECIFIC AIMS. FIRST, we will determine
the mechanisms and consequences of KC depletion induced by NLRP3 activation. We will test
the hypothesis that NLRP3 inflammasome activation in KCs leads to pyroptotic cell death and
the recruitment of MdMs to the liver. We will use a number of unique, genetically engineered
mice. To study the effects of KC-specific loss of function of NLRP3 during NASH we will use our
new floxed Nlrp3-/- mice on a fat-fructose-cholesterol diet that mimics human fibrotic-NASH. In
vivo experiments will be complemented with ex vivo assays using purified KCs, iPSCs and sc-
RNA transcriptomics. SECOND, we will dissect the role of cell-specific IL-18 signaling pathways
in NLRP3 mediated HSC activation and liver fibrosis. We will test the hypothesis that NLRP3
inflammasome activation in neutrophils and MdMs, followed by IL-18 signaling pathway
activation is a central driver of HSC activation and liver fibrosis. We will characterize the role of
IL-18 signaling and identify novel downstream mediators responsible for liver fibrosis. We will
generate floxed IL-18, or IL-18R1, or IL-18BP murine lines to study IL-18 signaling in a cell-
specific manner using neutrophil or macrophage-specific, NLRP3-driven models. We will also
assess cell-specific modulation of NLRP3/IL-18 signaling in murine NASH-associated fibrosis in
vivo. Finally, we will investigate translational mechanisms targeting the IL-18 pathway in fibrotic
liver disease.

Public health relevance
PROJECT NARRATIVE / RELEVANCE Cell death and inflammation are two central elements in the pathogenesis liver fibrosis, the central process leading to increased morbidity and mortality secondary to liver disease. We have uncovered a novel role of the NLRP3 inflammasome as a modulator of hepatic stellate cell biology, the key liver cell involved in activation of the fibrotic program and liver fibrosis. The studies in this application will focus on targeting novel mechanisms of inflammation, cell death, and fibrogenesis to inhibit or reverse the development of fibrosis in order to prevent morbidity and mortality associated with progressive liver disease.